Transcriptional Control of Gastrin

III. Abstract of Research Plan for Extension Period (5 years) 1. To examine the role of co-repressors, e.g., HDAC, Sin3A, in menin-mediated inhibition of gastrin 2. To examine the role of somatostatin in regulation of co-repressors 3. To determine the role of somatostatin and menin in the regulation of p27 and cell proliferation. Role of MLL. Are duodenal gastrinomas of myeloid origin?

Public health relevance
RELEVANCE (See instructions): Relevance to publish health include furthering our understanding of peptic ulcer disease, neuroendocrine transformation and the molecular basis underlying the effects of SOM analogs used to treat neuroendocrine disorders.